Cancer Research Career Enhancement and Related Activities

CORE 001 – CANCER RESEARCH CAREER ENHANCEMENT AND RELATED ACTIVITIES
PROJECT SUMMARY/ABSTRACT
Ensuring the highest quality cancer research education, training and career development is key to the mission
of the Vanderbilt-Ingram Cancer Center (VICC). VICC leadership and membership have catalyzed and
propelled Vanderbilt’s nationally recognized strengths in the training and mentoring of graduate students,
residents, postdoctoral fellows and faculty in cancer research careers to advance discovery and translation.
VICC recruits and invests in the career development of researchers, clinicians and allied-health professionals,
encompassing the spectrum of the cancer space; from basic, population-based, translational and clinical
research to clinical practice and patient care. VICC, through significant annual investment, has created and
facilitated robust and comprehensive cancer-focused training, education and mentoring activities. More than
525 faculty, over 3,400 allied-health professionals, and over 1,900 trainees (graduate students, postdoctoral
fellows, medical students, resident trainees, and clinical fellows) have participated in VICC-sponsored
educational and training activities since 2015, including ethics and responsible conduct of research, and ongoing
training of clinical fellows and staff. These activities are essential for the development of the next generation of
cancer researchers and clinicians and provide the foundation on which the greatest changes in cancer
incidence, morbidity and mortality will emerge. VICC has been deliberate in addressing the issues of diversity
in our workforce, providing enriching mentorship to >4000 underrepresented minority (URM) Kindergarten
through 12th grade (K-12) students (our future workforce), undergraduate students, graduate/postdoctoral
researchers, medical students and early career faculty. VICC members participate in the Vanderbilt Augmenting
Scholar Preparation and Integration with Research Related Endeavors (ASPIRE) and STEM educational
outreach to >6,000 K-12 and undergraduate students per year. Notably, the key education and training activities
address the academic challenges of rural Tennessee and the diverse population of the VICC catchment area
and extends these approaches globally. Academic and professional development activities are available to all
trainees and faculty through intensive mentored research engagement and/or formal research training, including
formal curricula in cancer biology. Further, 21 cancer-related T32 training programs support cancer career
development for trainees (six NCI-funded, catalyzed by VICC leadership), four institutional K12 awards along
with numerous individual F, NRSA, ACS, Komen, and DOD grants. Early career faculty benefit from team-
based, inter-disciplinary mentoring through advisory committees, grant writing studios and mock study sections.

Public health relevance
CORE 001 – CANCER RESEARCH CAREER ENHANCEMENT AND RELATED ACTIVITIES PROJECT NARRATIVE Per the PAR-17-095 FOA, the project narrative is not applicable for the Cancer Research Career Enhancement and Related Activities.